SIGNALLING MECHANISMS IN CNS DEVELOPMENT

Research conducted in the Unit on Developmental Biology is aimed towards the elucidation of the molecular mechanisms regulating the development of the central nervous system (CNS). The CNS develops through an orderly series of events that are governed by the genetic program and epigenetic signals. The anteroposterior and dorsoventral axis is determined during gastrulation ans early stages of neurogenesis. Subsequent steps involve proliferation of neuronal precursor cells, cell migration, axon outgrowth and the establishment of synaptic connections. The spatial and temporal pattern of these events are characteristic for each neuronal structure. Transgenic and embryonic stem cell technologies are employed to study the interaction between epigenetic signal and the neurogenic program in the development of the central nervous system.